Understanding the Interaction between Host Genetics, Immune response, and Gut Microbes in Post-operative Recurrence of Crohn's disease

Project Summary/Abstract
Intestinal resection remains a common complication in Crohn's disease (CD) despite the advent of advanced
biologics and small molecule therapies. Within one year after ileocolic resection, over 70% of patients with CD
are known to have endoscopic recurrence. Even in patients treated with a biologic treatment, 30% develops
recurrence of CD. Despite significant progress in the management of post-operative CD patients, there is still an
unmet need in efficiently treating and preventing recurrence of CD following ileal resection.
Since 2011, six participating Genetic Research Centres as part of the NIDDK Inflammatory Bowel Disease
Genetic Consortium (IBDGC) have recruited patients for the CD Ileal Post-Operative Study. The consortium-
wide effort has led to a creation of a large biobank of blood, stool, and biopsy samples during the peri-operative
period and at each follow-up post-operative endoscopic procedures. Although these efforts led to important
biomarker discoveries related to post-operative disease recurrence, the mechanism of intestinal inflammation
initiation after ileal resection is still unknown.
For this ancillary study proposal, we aim to better understand the pathophysiology of CD by leveraging the
NIDDK IBDGC Post-operative CD cohort. We propose to make use of the latest high-throughput omics
approaches to this cohort. First, an untargeted in-depth antibody repertoire profiling approach using phase
display technology (PhIP-Seq) will help us identify novel anti-microbial antibodies associated with disease
recurrence. Second, metagenome-assembled genome analysis (MAG) on stool and biopsy samples will help
identify novel gut microbial functional genomic signatures associated with post-operative CD recurrence.
Third, metabolomics analysis will help identify the downstream expression of various changes that occur in the
genome, proteome, and transcriptome, that will ultimately closely represent the phenotypic fingerprints of CD
recurrence. Additionally, the associations between anti-microbial antibodies, microbiome, and metabolome with
post-operative CD recurrence can be assessed for their dependence on specific known ileal CD-associated
genetic variants (e.g., located NOD2, ATG16L1, HLA-DRB1*07:01, LRRK2, MUC19) or combined CD-genetic
risk variants (e.g., CD-polygenic risk score). Taken together, through the research proposed, we anticipate that
significant advances will be made toward a better understanding of the mechanisms of intestinal inflammation
following ileal resection of CD and the translation of these data into clinically meaningful tools that will lead to a
lower recurrence of CD.

Public health relevance
Project Narrative For this Ancillary R01 study proposal, we will be working with the NIDDK IBD Genetics Consortium to apply the latest high-throughput omics approaches to one of the largest post-operative Crohn’s disease (CD) cohort to better understand the pathophysiology of CD. This proposal focuses on better elucidating how the complex relationship between host genetics, microbial and immune factors contribute to recurrence of CD from a “disease-free state” after resection of disease. Through the insights gained, we hope to reduce the risk of post- operative CD recurrence, change the nature course of disease, and improve the quality of life of individuals affected by CD.